Unfixed, xenogeneic extracellular matrix for crimp damage-resistant and regenerative transcatheter heart valve prostheses

ABSTRACT
In this Phase I SBIR application, ViVita Technologies, Inc. (Davis, CA) aims to validate its patented technology
(SPEAR PlatformTM; US 9,220,733) towards development of unfixed, immune-compatible, and regenerative
xenogeneic biomaterials for transcatheter heart valve replacements. In the U.S., 130,000 heart valve replacement
procedures are performed annually, a $2 billion burden. Glutaraldehyde-fixation of bioprosthesis biomaterials only
permits longevity of ~10 years in adults due to chronic immune rejection and resultant mechanical failure of the
biomaterial. Further, fixed biomaterials are incompatible with recipient cellular repopulation and regenerative
turnover; thus, they are non-living solutions. These deficiencies led the National Heart, Lung, and Blood Institute:
Cardiac Surgery Working Group to recommend future support of basic biomaterial research for valve bioprostheses
to improve durability. By targeting removal of the actual immunological barriers (i.e., cellular and non-cellular
antigens), the SPEAR PlatformTM produces unfixed biomaterials (BARETM patches; US 9,827,350) that avoid rapid
immune destruction, while maintaining the native extracellular matrix (ECM) structure-function relationships critical
for implant longevity and function. BARETM patches (1) elicit minimal graft-specific adaptive immune response,
thereby avoiding immune-mediated damage and associated calcification, (2) appear as “self” to the innate immune
system, facilitating integration with recipient tissue, and (3) promote rapid non-immune cellular repopulation and
resultant regeneration into patient tissue. To broaden the reach of our technology beyond surgical valve
replacements to include transcatheter alternatives, thinner BARETM patches generated from porcine pericardium
(BARE-Thin) will be necessary. Delivery of transcatheter aortic valve replacements (TAVRs), results in unavoidable
crimping of the valve biomaterial. Concerns have been raised that crimp-induced damage of valve biomaterials
compromises TAVR durability. Therefore, a biomaterial that avoids crimp damage may enable greater TAVR
durability. Further, pro-regenerative biomaterials which can be replaced by the patient’s tissue have the potential
to be a lifelong solution. This proposal will determine feasibility of BARE-Thin as a crimp-damage resistant TAVR
biomaterial. TAVRs will be manufactured from BARE-Thin or glutaraldehyde fixed-porcine pericardium and
crimped; biomaterial properties will be quantified to characterize resistance to damage and resultant effect on in
vitro durability (Goal 1). Additionally, conversion rate of BARE-Thin into recipient tissue will be quantified from in
vitro resorption (collagenase digestion model) and in vivo turnover (6-month ovine TAVR model) studies (Goal 2).
Like our previous SBIR efforts, all Goals have been developed in collaboration with our strategic partner, a leading
heart valve manufacturer. Successful completion of this Phase I work will provide critical insight and validation of
BARE-Thin as a next-generation TAVR biomaterial, overcoming concerns over crimp related damage and limited
longevity of current bioprostheses, by providing a crimp resistant, pro-regenerative biomaterial which affords a
lifelong cure.

Public health relevance
NARRATIVE American Heart Association estimates the prevalence of heart valve disease to be 2.5% in the U.S., requiring 130,000 heart valve replacement procedures per year at a cost of $2 billion. Current heart valve replacement biomaterials are subject to recipient immune-mediated attack, limiting implant longevity and necessitating repeat surgeries to replace damaged valves. ViVita Technologies, Inc. has developed a novel platform methodology (SPEAR PlatformTM) to remove immunological barriers from animal-derived tissues, producing an unfixed pericardium biomaterial (BARETM patch) which is compatible with patient’s immune system, integrates with their body, and fosters regenerative turnover into the patient’s own tissue over time—a biomaterial which may prove to be an ideal surgical and transcatheter heart valve replacement biomaterial that can also be translated to diverse cardiovascular applications.